Multimodal Characterization of a Novel Inherited Mouse Model of Glaucoma

ABSTRACT
Primary open-angle glaucoma (POAG) is a leading cause of irreversible blindness worldwide,
affecting over 80 million people. It is characterized by the progressive loss of retinal ganglion cells
(RGCs) and optic nerve damage. Elevated intraocular pressure (IOP) is causal risk factor of
glaucoma. While current treatments focus on lowering IOP, there is a critical need for therapeutic
strategies that target neuroprotection, as no existing treatments effectively prevent or slow RGC
death and axonal degeneration. Current animal models for glaucoma, such as inducible IOP elevation
models have limitations in replicating the gradual, spontaneous progression of human glaucoma.
Moreover, inherited mouse models, such as DBA/2J, exhibit slow and variable disease progression
and anterior segment inflammation. Glis1 knockout (KO) mice offer a novel genetic model to studying
glaucoma. GLIS1 is a Krüppel-like transcription factor predominantly expressed in the trabecular
meshwork (TM) and undetected in the retina. Importantly, GLIS1 deficiency induces progressive
degeneration of TM, leading to IOP elevation. Thus, this model provides a unique system to study
ocular hypertension-induced glaucomatous neurodegeneration without confounding effects of Glis1
deficiency in the retina. Moreover, Glis1 KO mice exhibit no major abnormalities outside the drainage
angle specific phenotype, making them ideal for longitudinal studies. Aim 1 will characterize
glaucoma-relevant phenotypes in Glis1 KO mice across two genetic backgrounds (C57BL/6J and
129S6/SvEvTac), evaluating structural and functional changes, including axonal degeneration, RGC
loss, dendritic changes, and neuroinflammatory responses. Aim 2 will identify molecular pathways
associated with glaucomatous neurodegeneration using single cell RNA sequencing (scRNA-seq) of
RGCs. Integrating findings of the gene expression changes with human POAG genome-wide
association studies (GWAS) with help prioritize candidate genes contributing to glaucoma. Our study
will establish the Glis1 KO model as a valuable resource for the glaucoma research community,
addressing limitations of existing models by offering a more physiologically relevant and reproducible
model for investigating glaucoma pathogenesis. Insights from this experimental glaucoma model may
lead to novel strategies for glaucoma treatment.

Public health relevance
PROJECT NARRATIVE Many important discoveries about glaucoma, a neurodegenerative disease of the optic nerve, have been made using animal models of glaucoma, but difficulties in reproducing findings across laboratories remains a major challenge. This project will comprehensively evaluate a novel inherited model of glaucoma that overcomes many of the challenges with existing animal models and will develop the model as a resource for the entire scientific community. New insights into the earliest stages of glaucoma will ultimately lead to the development of novel treatments and improve the quality of life for glaucoma patients.